AZT VS 2',3'DIDEOHYDRO-3'DEOXYTHYMIDINE IN CHILDREN W/HIV INFECTION

To look for safety, tolerance and effectiveness of a new drug called Stavudine, compared to a licensed drug Zidovudine in children ages 3 months to 17 years who are infected with HIV.